MS-based metabolite identification

Project Summary
This proposal aims to develop an innovative metabolite identification algorithm for metabolomics using liquid or
gas chromatography coupled with mass spectrometry (LC/GC-MS) by addressing two important components of
data analysis: peak detection and compound identification. Metabolomics has great potential to impact clinical
health practices due to its ability to rapidly analyze tissue or biofluid samples with little sample preparation, and
metabolomics provides information that complements the genomic and proteomic profile of a patient. However,
peak detection and compound identification remain as significant challenges for metabolomics. Low quality
signal hampers every step of data analyses including, but not limited, peak detection and compound identification.
In particular, metabolite identification accuracy suffers from a high rate of false identification that can mislead the
downstream analysis such as network construction and biomarker discovery. To alleviate these issues, we
propose to develop an innovative metabolite identification algorithm for LC/GC-MS based metabolomics, by
accomplishing two highly interconnected goals: peak detection and compound identification by generating
augmented signals and using both MS similarity and retention times. The proposed statistical/computational
approaches will lead to novel methodology for compound identification in analyzing LC/GC-MS data. The
metabolic identification algorithms developed from this project will enable accurate metabolite identification by
simultaneously considering MS similarity and retention time.

Public health relevance
Project Narrative Liquid or gas chromatography coupled with mass spectrometry (LC/GC-MS) is a key technology for metabolomics and is widely used for discovery of metabolite biomarkers that can be used as diagnostics, prevention and treatment of various diseases. This proposed research addresses a critical challenge in the compound identification of LC/GC-MS data by developing innovative peak detection and metabolite identification algorithms using advanced statistical and computational approaches.